Biomechanical regulation of chromatin states in lung cancer

PROJECT SUMMARY
The lung, a remarkable organ containing millions of air sacs or alveoli, facilitates gas exchange and serves as
a barrier to environmental insults. This dynamic organ undergoes constant mechanical forces: the average
human at rest takes 12-16 breaths per minute. Consequently, alveoli, comprised of alveolar type 2 (AT2) and
alveolar type 1 (AT1) cells, sense and translate these mechanical cues into biological signals to maintain tissue
homeostasis and alveolar identity. The nucleus, as the largest and stiffest organelle of the cell, is particularly
sensitive to these physical forces. Healthy cells, through activation of the mechanosensory PIEZO1, will initiate
robust responses to mechanical forces through the reorganization of the enclosed chromatin without altering
cellular function. However, in lung cancer, the stiffened tumor microenvironment disrupts these essential
mechanical cues, leading to the dysregulation of mechanosensing pathways. The mechanisms by which
changes in the force experience of AT2 cells, a predicted cell-of-origin of lung adenocarcinoma (LUAD),
contribute to the loss of alveolar identity, cellular diversification, and subsequent disease progression are not
yet established. Our lab recently discovered that CEBPA, a master regulator of alveolar cell fate, can bind the
Piezo1 locus and regulate calcium signaling. Interestingly, dysregulation of CEBPA and subsequent alterations
in calcium signaling contribute to accelerated alveolar fate transitions and disease progression. Additionally,
we have identified that PIEZO1 is progressively downregulated in lung cancer and clinical observations
associate its genetic depletion with a worse prognosis. Given the interplay between CEBPA, PIEZO1, and
calcium signaling, we hypothesize that these factors, in concert, are crucial for maintaining mechano-chromatin
homeostasis in the lung. To test our hypothesis, we will leverage our expertise in murine modeling and
epigenomic technologies to address two aims. The first aim will study how PIEZO1 and CEBPA regulate
chromatin remodeling events in LUAD cell lines following cell stretch exposure using a cell stretching device
that mimics the physiological changes experienced during breathing. By subjecting cells to stretch, we can
observe the resulting changes in chromatin accessibility, transcription factor activity, and nuclear architecture.
The second aim will characterize the role of PIEZO1- and CEBPA-dependent mechanosensing in lung cancer
progression. To do so, I will take advantage of newly generated mouse models in which PIEZO1 or CEBPA are
depleted in combination with the activation of oncogenic mutations. My work will investigate how the loss of
either gene abrogates force sensing, which can lead to increased tumor burden or severity and increased
cellular diversification. The long-standing implications of my project are that restoration of homeostatic
mechanotransduction pathways regulated by PIEZO1 and CEBPA may ameliorate lung cancer and have broad
applications to cancers of other organs with similar transitions in their mechanical microenvironments.

Public health relevance
PROJECT NARRATIVE Healthy lung tissue constantly adapts to mechanical forces, maintaining its function through a delicate interplay between physical cues and chromatin organization. However, in lung cancer, these homeostatic processes are disrupted, leading to cellular diversification and disease progression. This project aims to understand how disrupted mechanical signaling impacts chromatin remodeling events that contribute to lung cancer development, focusing on the roles of PIEZO1 and CEBPA, to identify novel therapeutic strategies.